A Naloxone Parachute: Novel Wearable Dual-Sensor Regional Oximeter to Detect Opioid-Induced Hypoxia and Enable Emergent Naloxone Rescue

SBIR PHASE II - ABSTRACT
Ayuda Medical has the vision that no-one should die from a treatable medical emergency. Opioid
overdoses (OODs) are treatable with basic CardioPulmonary Resuscitation (CPR), but they claimed over 250
lives each day in the US in 2020. Patients most at risk for OOD are people in treatment for Opioid Use
Disorder (OUD) or High Impact Chronic Pain (HICP). The current standard of care to OOD is bystander
response (medical or nonmedical), but the bystander needs to know that an OOD is occurring. We present a
wearable medical diagnostic device to detect OOD and bridge the gap to bystander intervention.
Our device, Parachute ARMband, will be worn continuously, and will monitor physiologic parameters
that indicate OOD, then will use an on-device escalating tonal alarm to summon bystanders, as well as on-
device speaker to verbally identify the urgency to get medical help. No wireless connectivity is required for
these functions. The ARMband will also send a Bluetooth alert to an adjunct Mobile Medical Application
(MMA) on the User’s phone, that can reach designated contacts, previously chosen by the device user. This
function requires mobile device connectivity, and that the MMA be downloaded prior to the medical event.
Company has completed a Phase I SBIR, sponsored by National Institute of Drug Abuse (NIDA), that
showed the upper arm is a viable location for wearable oximeters, main components of novel device. The
addition of Phase I Innovation Corps enabled company to validate Minimal Viable Product (MVP) key features,
including escalating alarm and wireless alert. Together our Phase I learnings allowed Principle Investigator
(PI) to submit a Breakthrough Device Designation (BDD) request to the FDA.
This proposed Phase II application will show feasibility of our novel device components to detect gas-
induced hypoxia, compared to arterial blood gas (Aim 1); sensitivity of device to detect intravenous remifentanil
“OOD” and begin alarm algorithm (Aim 2); and ability of device communications to send a real-time wireless
alert (Aim 3). These three aims support device safety and effectiveness. In Aim 4, Human Factors and
Instructions for Use (IFU) are specifically tested in our target population, persons with a history of OUD or
OOD. Aim 5 likewise tests the device in our target population, but also adds our target use environment; it will
test device’s wearability via 48hr and and two-to-four week take home studies.
Together all five Aims, along with non-clinical testing of device design and alarms, will support seeking
Class II marketing via a De Novo submission, with the device indicated for People Who Use Opioids (PWUOs)
including HICP, and people with a history of OUD that are at risk for OOD. To date there is no FDA approved
device to monitor for OOD. We offer a continuous monitor because stressors and triggers to opioid use can be
unexpected. The De Novo submission will include data from studies designed for our target clinical scenario
(acute opioid ingestion/ administration), and target use environment (ambulatory, at-home).
Ayuda Medical plans to have several discussions with the United States Food and Drug Administration
(FDA), throughout device development and Phase II. BDD was submitted in Q3, 2021, and company plans to
submit a Q-sub clarifying our milestones to approval in Q4, 2021. We plan to use early gas hypoxia studies
(Aim 1A) to apply for Investigational Device Exemption (IDE), and then perform clinical studies with opioid-
specific protocols (Aims 2 and 3). This includes feasibility (Q4, 2022) and pivotal (Q4, 2023) studies
sponsored by Phase II. Continuous interactions with FDA will align company milestones with FDA objectives.
Commercialization strategy includes seeking federal Medicaid coverage in tandem with FDA approval,
as part of a dual-panel (FDA-CMS) pre-marketing review. Company plans to market the ARMband directly
within the OUD market, and co-market the device with a strategic partner within the HICP market. We also
intend to conduct community-based pilot studies in collaboration with NIDA and the Substance Abuse and
Mental Health Services Administration (SAMHSA), to validate device system in specific to the OUD/HICP
populations in target environment, and to support formulary inclusion by State Medicaid. State Medicaid
coverage assures that the device is affordable and accessible by Community Health Centers (CHCs), that treat
the majority of the low-income populations for both chronic and acute illnesses, including OUD and OOD.
Establishing a viable commercial path via state Medicaid and CHCs, that can then be expanded into 50 states,
is an attractive proposal to partnerships and potential exit companies in the OUD market.
Phase I validated device need and feasibility of our development approach. Phase II will provide the
appropriate clinical and non-clinical testing to support a De Novo submission to the FDA. Company is fully
dedicated to the approval and commercialization of the Parachute ARMband OOD diagnostic device, and to
making it available to all at-risk groups, aiming to expand the protection against accidental opioid overdose.

Public health relevance
2021 09, Hite, Naloxone Parachute: Novel Wearable Dual Sensor Regional Oximeter to Detect Opioid-Induced Hypoxia and Enable Emergent Naloxone Rescue NARRATIVE: We are developing a wearable Opioid Overdose (OOD) Diagnostic device, that will decrease the time from OOD to recognition by bystanders, and therefore decrease time to resuscitation (and possible naloxone administration), with a goal to reduce the fatality rate of OOD in the ambulatory setting. A discreet biosensor device that detects life-threatening OOD with on-device logic and alarms locally, without wireless connectivity needed, is a fundamental improvement in patient safety because it removes all risk of connectivity (e.g. wearable device to mobile-device of User, and then to cloud for data analysis and response, introduces many opportunities for error), and enables patients to be rescued in a variety of circumstances where wireless connection may not be present to transmit the acute event (basement, car, etc). The addition of an adjunct (not required for device function) wireless alert, to people who have been specifically selected by the device User, adds an additional opportunity for intervention in OOD, giving agency to loved ones to act in case of an emergency (they may be nearby, or can call 911) - expanding the opportunities for intervention improves the likelihood of preventing fatal OOD.